SMART Methodology for Constucting Adaptive Interventions

The long-term goal of this project is to improve clinical practice and thus public health by facilitating the evidence-based construction of efficacious, individualized, i.e., adaptive, interventions and treatments in drug abuse. Clinicians naturally adapt the level and type of therapy according to patient outcomes such as severity, response to past therapy, risk, stressors, adherence, preference and burden. This project will develop methods for using data to inform and enhance this adaptive clinical practice. Adaptive interventions are composed of operationalized decision rules that input patient outcomes and output recommended alterations in intensity and/or type of therapy. The construction of adaptive interventions requires addressing questions such as, How do we best use measures of risk and other outcomes in order to decide when a patient's therapy needs to be intensified or stepped down?. What sequence of therapies is best for achieving maximal improvement or preventing drug dependence? and Should this sequence of therapies vary by patient outcomes? This project facilitates the construction of adaptive interventions by developing the following methodological innovations. First, the SMART experimental design methodology will be extended for use with time varying outcomes; in particular this component will provide guidance to researchers on how to match their use of the time varying outcome in the data analysis of SMART studies to their prevention/clinical goals. Second, this component will generalize a data analytic method from engineering and computer science for use with SMART study data so as to develop adaptive behavioral or combined behavioral/pharmacological interventions. Third, this component will provide methods for using data to construct more flexible adaptive interventions. This innovation will be achieved by constructing measures of confidence that can be used to ascertain when there is no evidence to discriminate between two or more successful treatments as part of an adaptive intervention. This work will include collaborative research with health scientists interested in constructing adaptive interventions. The goal is to accelerate the improvement of both drug abuse prevention programs and treatments.

Public health relevance
Drug abuse and dependence are costly to society; this project will improve clinical practice and thus public health by facilitating efficient, evidence-based construction of efficacious, individualized interventions to combat drug abuse.